FoxO1 protects the heart against ischemia

Summary
Forkhead box protein O (FoxO) family transcription factors are evolutionarily conserved proteins that play
essential roles during development and in postnatal physiology in the heart. FoxOs play a dichotomous role in
the regulation of cell survival/death in a context-dependent manner: they mediate cardiomyocyte (CM) cell
death under some conditions but promote cell survival under other conditions. FoxOs can promote cell death
by stimulating transcription of Bim, TRAIL, FasL, Bcl-6 and NOXA or lead to insulin resistance by
downregulating IRS. On the other hand, endogenous FoxOs promote CM survival in response to oxidative
stress and mediate the pro-survival effects of Sirt1 in CMs during ischemia/reperfusion (I/R). Moreover, FoxO1-
dependent transcription of autophagy genes is required for survival of CMs during starvation. At present,
however, how FoxOs mediate their dichotomous cellular functions is not well understood. Better understanding
of the underlying mechanisms may make it possible to promote only the salutary function of FoxO1 while
inhibiting the pro-death function of FoxO1 in the heart in the clinical setting. Our preliminary results suggest
that Mst1, a pro-apoptotic kinase, can convert FoxO1 from pro-apoptotic to pro-survival through sequential
phosphorylation of FoxO1 and C/EBP- in CMs. Our overall hypothesis is that Mst1 converts the function of
the transcription factor FoxO1 from pro-apoptotic to pro-survival through sequential phosphorylation of FoxO1
at the DNA binding domain (DBD) and C/EBP-at Thr250 (mouse). We will: Aim 1 Show that FoxO1
promotes CM survival during myocardial ischemia and I/R through Mst1-induced phosphorylation of at
the DBD; Aim 2 Demonstrate that Mst1 induces dissociation of FoxO1 from the promoter of pro-
apoptotic FoxO target genes and association with C/EBP- to promote transcription of pro-survival
molecules; Aim 3 Demonstrate that Mst1-induced phosphorylation of C/EBP- at Thr250 is FoxO1-
dependent, and that Thr250 phosphorylation of C/EBP- promotes transcription of pro-survival factors;
Aim 4 Demonstrate that C/EBP- phosphorylation at Thr250 is salutary and plays an essential role in
mediating the salutary effect of the Mst1-FoxO1 pathway during ischemia and I/R. We will use cardiac-
specific FoxO1 knockout (KO) (FoxO1cKO) and cardiac-specific C/EBP- KO (C/EBP- cKO) mice, as well as
newly generated C/EBP- (T250E) knock-in (KI) mice in conjunction with AAV-mediated gene delivery and
proteomics. Our study will elucidate the molecular mechanism by which FoxO transcription factors regulate
directionally opposite cellular functions, namely survival and death, in a coordinated manner and through
interaction with Mst1 and C/EBP-. Knowledge obtained from this study should be useful for the development
of molecular interventions to convert the function of FoxO transcription factors from dichotomous to fully
cardioprotective and facilitate survival of CMs in the setting of myocardial injury.

Public health relevance
Summary narrative Myocardial ischemia and coronary reperfusion after ischemia cause myocardial infarction and arrhythmia and lead to patient death. Among the patients who survive, many develop heart failure. Thus, investigating the mechanisms that protect the heart during ischemia and reperfusion is important. We will investigate a novel mechanism of protection against myocardial injury induced by ischemia and reperfusion. The proposed mechanism is innovative because it can convert the function of an endogenous protein in the nucleus from detrimental to salutary so that genes known to protect the heart are upregulated during myocardial ischemia and reperfusion. We will use unique mouse models to address the hypothesis. Knowledge obtained from this investigation should be useful for the development of a novel treatment for patients with ischemic heart disease.